Core E: Laboratory and biobehavioral marker core

CORE E: ABSTRACT/SUMMARY
Consistent with the Center's theme, the mission of Core E is to facilitate a broad range of biological and
behavioral intervention studies that are designed to optimize psychiatric, behavioral, and medical outcomes
among HIV infected individuals. The Core will perform assays for all Pilot Projects, as well as design and
implement novel assays. This Core will perform laboratory and imaging assessments that define the mental
illnesses and co-morbidities related to HIV/AIDS and unique modeling and measurements related to various
behavioral and pharmacologic interventions. The Core will benefit from the major strengths of the Perelman
School of Medicine (PSOM), CHOP, Centers, Departments, and Schools at UPenn. We will identify specific
and potentially unique biomarkers which are related to mental illness and to comorbidities of HIV/AIDS. These
data will be collected for all subjects to be studied in pilots and other Cores. The Core will perform assays of
body fluids and cells including markers of immunity, inflammation, stress, and health. The Core will also carry
out neuroimaging and neurocognitive measures. The Core will assessments related to therapeutics for HIV,
mental health, and co-morbidities. The Core is directed by two senior investigators, Drs. Douglas and Gur. The
Core will support the Center's scientific agenda and developmental program. This Core resource will closely
interact with existing resources at UPenn, which are central to the mission of the PMHARC. The Core Director,
Douglas, and Co-Director, Gur, are in leadership roles at UPenn. The Core will be uniquely positioned to carry
out and monitor the quality control and quality assurance of standardized selected imaging, biochemical
markers, neuropsychological behavioral testing, and laboratory testing. The Core will work closely with all the
other PMHARC Cores, and most closely with the Clinical Assessment Core, in an effort to gather integrated
'state-of-the-art' biomedical and behavioral data on a cohort of HIV+ persons with a variety of mental illnesses
in an effort to better understand disease trajectories, morbidities and clinical outcomes.